Assessment of traumatic experiences among young children: Examining measurement factors that influence parent report and predictability

Project Summary/Abstract Exposure to potentially traumatic events (PTEs) has become an important public health issue given that as much as 75% of children experience at least one PTE before reaching adolescence and approximately half of these children will demonstrate impairments or delays in their behavioral, academic, social, or physical health. However, the field of research that seeks to better understand the connection between PTE exposure and children's well-being continues to develop from inadequate practices in PTE exposure assessment with no commonly accepted and validated approaches when relying on caregiver report for a child's experiences. Understanding best practices of PTE assessment from caregiver report is essential for creating accurate and replicable research on PTE exposure in children, as well as guiding clinical practice in identifying children for services while also minimizing service cost and burden. The proposed study will address these gaps in understanding by providing empirical data that examines the content and accuracy of information on children's PTE exposure obtained between questionnaire and interview formats (Aim 1) and tests the predictive power of information obtained between different levels of assessment detail or depth (Aim 2). Participants will include 160 children ages 3-7 and their caregiver, drawn from a larger, longitudinal R01, the “Preschoolers' Adjustment and Intergenerational Risk” (PAIR) Project. The current study will improve on past methodological weaknesses by using equivalent assessment tools across formats to isolate factors associated with format and not simply content of the measure, while also utilizing novel statistical approaches to determine the utility of information obtained on children's PTEs (e.g., type, frequency, severity). The results from this study will help advance the field by determining the strengths and weaknesses of PTE assessment approaches in their ability to predict the influence of PTE on children's functioning. The training plan developed for the project will allow for the successful completion of the project and development of the applicant toward the next stages in the applicant's research career. This project will permit training for the applicant in (a) a wide array of trauma assessment instruments, (b) advanced statistical techniques, (c) trauma informed care practices, (d) responsible conduct of research, and (e) manuscript and grant writing. The training team involved on the proposed project is well-suited for achieving these training goals and addressing the research aims of the project. Further, the training environment at the University of Kansas and established infrastructure through of the PAIR Project will provide the applicant with the necessary resources to successfully carry out the proposed project.

Public health relevance
Project Narrative Exposure to potentially traumatic events (PTEs) increases risk for mental and physical health problems and functioning impairment in children, but the research that seeks to better understand these relations is considerably limited by its approaches to measuring and conceptualizing trauma. Using a highly novel and innovative approach, the proposed study will examine (a) how parent report of their child's PTE experiences differs between assessment formats (e.g., interview vs. questionnaire) and (b) how much information is needed on children's PTE experiences to accurately predict functioning. The findings of this study will provide needed empirical data that guides how researchers assess for PTEs and will aid in the development of assessment practices among trauma informed systems of care.